Mechanisms that underpin immunoglobulin gene rearrangement

Project summary/Abstract
Antibodies are encoded by three loci: (i) the immunoglobulin heavy chain (Igh) locus, (ii) the
immunoglobulin kappa (Igk locus and (iii) the immunoglobulin lambda (Igl locus. The Igh locus is
segregated into variable (V), diversity (D), joining (J) and constant (C) regions. The Igk and Igl are
comprised of V, J and C regions but lack D elements. The Igh and Igk loci utilize different mechanisms
to generate VHDHJH or VkJk joints. Igh locus rearrangement is instructed by RAG scanning involving loop
extrusion that pulls DHJH elements along chromatin until they align with VH gene segments to undergo
VH-DHJH rearrangement. Vk-Jk locus rearrangement is regulated by changes in chromatin folding that
brings distally-located Vk genes within close spatial proximity of Jk gene segments. The joining of Vk
and Jk elements is regulated by enhancers, including the intronic Igk locus enhancer (iEκ), located in a
genomic region separating Jk from Ck, and an enhancer, E34, that is positioned in the Igk variable region.
iEk facilitates Vk-Jk joining involving Vk gene segments that span the entire Igk locus. E34 instructs Vk-
Jk rearrangements involving Vk genes that are located nearby. We recently demonstrated that the E34
enhancer repositions a loop domain that harbors a subset of Vk genes into a recombination hub that is
shared with Jk gene segments and the iEk enhancer. We showed the E34 deposits H3K27Ac across the
enhancer region. We postulated that E34-mediated deposition of H3K27Ac constructs a confined spatial
environment to prevent displacement of Vk from Jk gene segments (sub-diffusive motion). Here, we seek
to determine how enhancers and epigenetics regulate Vk-Jk chromatin dynamics. In aim 1 we would
develop a strategy to determine in quantitative terms, whether and how enhancers orchestrate Vk-Jk
chromatin dynamics and instruct a sub-diffusive environment to enrich for Vk-Jk encounters. In aim 2 we
would seek to determine whether epigenetic marks deposited across the E34 enhancer dictate Vk-Jk
sub-diffusive motion and spatial confinement to increase Vk-Jk interaction- and Vk-Jk rearrangement-
frequencies. The proposed method would enable us to determine how in 4D space enhancers and
epigenetic modifications enrich for Vk-Jk encounters to generate diverse antibody repertoires.

Public health relevance
HEALTH RELEVANCE: B-cells serve unique and important roles within the immune system including the production of antibodies. Generating new knowledge as to how a diverse antibody repertoire is generated will help to engineer the genome such that it will enrich for antibodies directed against distinct pathogens. Here we seek to develop an approach that would reveal how epigenetic modifications instruct the generation of a specific antibody repertoire.